Defining the molecular determinants of inflammatory memory in the pancreas

Project Summary / Abstract
Biological systems operate within fluctuating environments, and, therefore, are inherently tasked with accurately
responding in real-time to a myriad of signals. Recent evidence suggests that a memory of inflammation can be
encoded and retained in the epigenome of cells even following resolution of the initial stimulus. The presence of
`inflammatory memory' suggests that preservation of tissue homeostasis also incorporates an evolutionary
adaptation in which future responses are educated by past experiences.
Inflammation is essential to the disruption of tissue homeostasis, and, in the pancreas, can destabilize the identity
of terminally differentiated acinar cells. Recently, we have employed lineage-traced mouse models to delineate
the chromatin dynamics that accompany the cycle of metaplasia and regeneration following pancreatitis, and
unveiled the presence of an epigenetic memory of inflammation in the pancreatic acinar cell compartment. We
have observed that despite histologic resolution of pancreatitis, acinar cells fail to return to their molecular
baseline after several months, representing an incomplete cell fate decision – one wherein there is persistent
MAPK signaling, AP-1 activation, and IL-33 in the pancreas microenvironment. In vivo, this epigenetic memory
controls lineage plasticity, with diminished metaplasia in response to a second inflammatory insult but increased
tumorigenesis with an oncogenic Kras mutation. We have demonstrated that both persistent chromatin and
transcriptional changes constituting memory can be specifically recalled in the response to oncogenic stress.
Together, our findings have defined the dynamics and recall of an epigenetic memory of inflammation that
impacts cell fate decisions.
In this proposal, we focus on building an understanding of the molecular underpinnings of memory of
inflammation. Specifically, we will leverage our lineage-traced mouse models of pancreatic inflammation to
establish an understanding of AP-1 binding to chromatin and its interaction partners (Aim 1). We will also employ
specific genetic and pharmacologic perturbations to AP-1 factors and MAPK signaling in vivo to articulate
whether epigenetic memory is reversible (i.e. inducing epigenetic `amnesia') (Aim 2). Third, we will examine the
role of IL-33 as a cell-extrinsic factor driving the memory phenotype (Aim 3).
Together our studies will define the molecular mechanisms that govern epigenetic memory of inflammation in
the pancreas. In so doing, we expect to uncover the key cell types, transcription factors, and signaling
intermediates that lead to persistent molecular alterations following transient injury. In turn, this work will shed
new light in to how memory can be targeted to abrogate the diminished threshold for tumorigenesis. By analyzing
the rational means for inducing epigenetic `amnesia', we will exploit the therapeutic opportunity that the durability
of epigenetic memory offers to address the lasting implications of an inflammatory insult.

Public health relevance
PROJECT NARRATIVE The focus of this research is to define the molecular determinants of memory of inflammation in the pancreas. Our proposal utilizes mouse models to establish that inflammatory memory in acinar cells features the AP-1 transcription factors and their binding partners; can be reversed through targeting of MAPK signaling upstream of AP-1 or AP-1 itself; and is driven by the effect of the cytokine IL-33 on acinar cells. These findings will drive our mechanistic understanding of inflammatory memory as a key target to ameliorate the sequelae of long-term consequences of inflammation in human disease.